Real-world and Innovative Multimodal Prediction and Prevention of Postoperative Mortality and Multi-morbidity

PROJECT SUMMARY
Of the >50 million Americans who undergo surgery annually, ~40% are >65 years of age. Age — one of the
strongest predictors of high risk for surgical complications — is associated with frailty, postoperative delirium,
cognitive dysfunction, Alzheimer's disease (AD), AD related dementia (ADRD) and accelerated age-related
cognitive decline (ARCD). These elderly surgical patients frequently present with multiple chronic conditions
including cardiac and vascular disease, hypertension, and cognitive disorders, contributing to increased risk for
poor perioperative outcomes. Thirty (30)-day postoperative mortality is the third leading cause of mortality in the
U.S. Postoperative major adverse cardiac and cerebrovascular events (MACCE) occur in up to 15% of patients.
Delirium and POCD are the most common perioperative complications in patients over 65 years (~30%), and
early evidence suggest that delirium and POCD, which are preventable with specific interventions, may
contribute to development or progression of AD/ADRD/ARCD. As severity of POD is associated with the greatest
rate of cognitive decline, efforts to prevent POD and POCD may offer protection against long-term cognitive
decline, AD and ADRD. Reducing unacceptably high postoperative mortality, costly and debilitating
postoperative multiple morbidity including postoperative delirium, cognitive decline and MACCE in the
vulnerable elderly surgical population is a critical unmet public health need. It is essential to develop an
effective evidence-based approach to providing value-based perioperative care in the high-risk surgical patients.
Currently, there is a lack of highly reliable, widely applicable, preoperative risk prediction tools for proactive
identification of high-risk patients and lack of evidence-based personalized perioperative interventions with
demonstrated efficacy on immediate and long-term postoperative cognitive and physical outcomes. Effective,
standardized, and broad scalable implementation of value-based programs for high-risk patients requires
automated and accurate risk models that can provide timely information prior to elective surgery, to allow for pre-
intra- and post-operative interventions to be successful. The goal of this R01 is to combine robust, effective, and
scalable preoperative and intraoperative risk-prediction tools for reliable stratification of high-risk patients, and
enable proactive multimodal preoperative prehabilitation, and perioperative physical/behavioral/cognitive
interventions to reduce postoperative delirium, cognitive decline, depression, MACCE, accelerated dementia
and mortality. Proposed large rigorous perioperative longitudinal intervention trials will provide robust,
prospective, and longitudinal evidence to support scalable and validated approaches for proactive risk mitigation
with preoperative prehabilitation as well as proactive multimodal pre- and intraoperative interventions to
significantly reduce postoperative delirium, cognitive decline, depression, MACCE, accelerated dementia and
mortality in millions of vulnerable elderly Americans each year.

Public health relevance
Project Narrative In older Americans undergoing high-risk surgeries, high postoperative mortality, stroke, heart attack, delirium, accelerated cognitive dysfunction, Alzheimer’s Disease and Alzheimer’s Disease-related Dementias are major clinical and public health problems, and lack of effective proactive interventions to prevent them is an unmet clinical need. This transformational perioperative interventional research has significant public health relevance, as it aims to reduce postoperative mortality, major, devastating, and costly complications including accelerated postoperative cognitive decline, Alzheimer’s Disease, and related Dementias. By providing targeted evidence-based preoperative prehabilitation, and proactive multimodal risk mitigation perioperative interventions, this research will significantly reduce postoperative mortality, stroke, major cardiac events, delirium, rapid cognitive decline, dementia, and depression in millions of older Americans undergoing high-risk elective surgeries every year.